Statistical methods for HIV-1 immune correlates studies

? DESCRIPTION (provided by applicant): Finding vaccine-induced immune response biomarkers that predict vaccine-protection against HIV-1 and other signiﬁcant pathogen infection, and understanding their role as mechanisms of protection, is an essential part of vaccine research. We distinguish three stages in immune correlates studies. The ﬁrst stage deals with measurement of immune response and may involve experimental design. The second stage performs preprocessing of immune response variables obtained in the ﬁrst stage to form composite immune response variables. The third stage examines the association between clinical outcome and immune response variables. We will develop novel statistical methods for each stage in order to increase the signal- to-noise ratio in immune response measurement, create immune response scores with maximum signal diversity, and increase the power of hypothesis testing by using change point regression model.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project aims to improve the power of immune correlates studies by developing new and improved methods for all three stages of immune correlates studies: measuring immune responses, preprocessing immune response variables, and identifying immune responses associated with HIV-1 infection/transmission.